Southeastern Coastal Center for Agricultural Health and Safety (SCCAHS)

PROJECT SUMMARY/ABSTRACT
The Southeastern Coastal Center for Agricultural Safety and Health (SCCAHS) builds on strong partnerships
among health disparate farmworker, fisher and forestry communities, frontline public health practitioners, and
scientists engaged in transdisciplinary occupational health research across the Southeast and U.S. Caribbean
regions. The multidisciplinary, inter-institutional network of projects, programs and Cores SCCAHS will
implement innovative research approaches and develop tailored, system-driven translation and dissemination
strategies drawing from environmental and human toxicology, occupational medicine, public health and
biomedical informatics research. The proposed Center includes an Evaluation and Planning Core (with
Administration; Evaluation; Diversity Equity and Inclusion; and Emerging Issues Programs), an Outreach Core,
and a Research Core. Proposed research projects and the focus of the Pilot/Feasibility Program include
activities within all four categories detailed in the PAR (basic/etiologic, intervention, translation, and
surveillance). Targets areas of concern include respiratory health, chronic kidney disease and musculoskeletal
disorders; cross-cutting themes include surveillance and mental health/substance abuse. Research projects
include the following:
Category I: Basic/Etiological
• Assess Personal Air Particulate and Pesticide Exposure and Respiratory Health Outcomes among
Farmworkers in the Southeast (Tara Sabo-Attwood, Environmental and Global Health, UF College of
Public Health and Health Professions).
• Development of urinary biomarkers of occupational stress in agricultural workers (Christopher Vulpe,
Center for Environmental and Human Toxicology, UF College of Veterinary Medicine)
Category II: Intervention
• Effectiveness and implementation of self-management strategies for low back pain among aquaculture and
horticulture workers (Kimberly Dunleavy, Physical Therapy, UF College of Public Health and Health
Professions)
Category III: Surveillance
• Detection of Chronic Kidney Disease of Unknown Etiology in Florida by Repurposing a Statewide Data
Infrastructure for Surveillance (William Hogan, Health Outcomes and Biomedical Informatics, UF College of
Medicine)
Category IV: Public Health Translation
The Pilot/Feasibility Program will seek to fund new- and early- stage investigators along the translational
science spectrum to study health outcomes at the population level (annual competitive seed funding)

Public health relevance
PROJECT NARRATIVE The goal of the proposed NIOSH Southeastern and Coastal Center for Agricultural Safety and Health (SCCAHS) is to address unique occupational safety and health challenges for populations working in agriculture, fishing, and forestry in the southern and coastal states of Florida, Georgia, Alabama, Mississippi, North and South Carolina as well as the U.S. Caribbean. SCCAHS will accomplish this through an interdisciplinary network of projects including six major universities in the Southeastern United States and U.S. Caribbean: University of Florida, University of South Florida, Florida State University, Florida A&M University (FAMU), Emory University, Morehouse School of Medicine and the University of the Virgin Islands (UVI).